Core 1: Administrative Core

Abstract
The Administration of the U19 will build on strategies learned and used over the last 15 years of management
of numerous interdisciplinary centers, program projects, consortia, and public/private research collaborations.
The greatest strength of our interdisciplinary resource program is a highly experienced and diverse team of
investigators who have worked together productively for a very long time. Our program is highly focused on
the development and application of state-of-the-art technology. Our resource leverages a unique group of
individuals who are in a strong position to bring these technologies forward into a series of deliverables to
make a translational impact to monitor Alzheimer's disease progression and/or response to treatment. We will
continue to use the administrative capabilities we have learned and put in place over the last 15 years to
ensure an effective and functioning resource for the scientific community.